SAGE to identify pathways important in melanoma progress

The resulting statistics of recurrent melanoma indicate a dearth of effective treatments for this disease. In order to identify targets for improved therapy, and to better elucidate the mechanisms underlying the pathogenesis of this disease, we are performing gene expression profiling of human melanoma biopsies. Although there are microarray-based gene expression profiling studies of melanoma available, few, if any, are performed using tissue, as finding a source of material that is of sufficient quality to perform these experiments is nigh impossible. Using a technique known as the serial analysis of gene expression (SAGE), which allows for the quantification of individual transcripts within a cell, as well as identifies novel transcripts, we can study the gene expression profiles of melanomas at different stages in this disease using minute amounts of tissue. Currently, available on the public databases are three libraries, which we generated from three melanoma tissues, representing two vertical growth phase tumors, and one distant metastasis. In progress are libraries from compound nevi, more metastases and melanocytes. By using analysis most often reserved for microarray studies, we can examine these data using tools rarely used to analyze SAGE data. These types of analyses can reveal which genes underlie progression and which genes might make viable targets for future therapy. Thus far, data generated by microarray analysis as well as SAGE have highlighted the importance of G-protein mediated signaling, resulting in the activation of PKC and rises in intracellular calcium in melanoma progression. These effects can be mediated by the gene WNT5A, the over expression of which can lead to increases in melanoma cell motility and invasion. RNAi inhibition of this pathway, followed by microarray analysis, reveals that Wnt5a may make this contribution to invasion by silencing the expression of metastasis suppressers such as Kiss-1 and NME-1. Experiments are underway to determine the mechanism of this reversible, Wnt5a-mediated silencing. In addition, Wnt5a can suppress the expression of melanoma antigens, implying it may play a role in escaping immune surveillance. Other calcium -regulated genes were also identified by SAGE as highly expressed in melanoma, and their presence has been confirmed by tissue microarray analysis. It is hoped that identifying important pathways such as these with these high throughput gene expression profiling techniques will lead to identifying better molecular targets for treating this disease.